Quantifying Conflict and its Association with Cholera in Yemen

Project Summary
Since 2014, Yemen has been embroiled in a protracted conflict that has left over 80% of its population in
need of humanitarian aid and protection. Yemen faced significant vulnerabilities before the conflict, including a
poor economy, food insecurity, fragile healthcare system, and insufficient water, sanitation, and hygiene
infrastructure. Now, over 4 million individuals have been displaced, and most of the population is impoverished.
Communicable diseases have increased during conflict; the clearest example of this is the cholera outbreak that
began in 2016, which is considered the largest cholera outbreak in recent history with over 2.5 million cases and
4,000 related deaths. Only half of Yemen’s health facilities are considered fully functional, making the health
system insufficient to meet this increased demand for care. Much of this reduced functionality comes from air
raids on the facilities, which have become a central component of the conflict’s violence. However, existing
measures do not capture the full extent of conflict’s effect on infrastructure, which is critical in the mechanism
between conflict and increased disease incidence. This includes infrastructural rebuilding, which is an important
consideration in protracted conflicts as it can help reduce further spread of disease.
The overall goal of this proposal is to quantify and assess the association between conflict and
cholera in Yemen. The first Aim towards this end is to build a model that measures the association between
conflict and cholera while incorporating environmental, economic, demographic, and spatial factors relevant to
cholera’s epidemiology. The second Aim will utilize earth observation tools, including nighttime light and synthetic
aperture radar, to measure infrastructure changes and assess whether this conflict measurement better predicts
cholera cases. I will also use data from this aim to incorporate infrastructural rebuilding into the first Aim’s model.
Lastly, my findings from Aims 1 and 2 will be used to project future cholera outbreaks under different conflict,
climate, and economic scenarios. Overall, these findings will have important implications for understanding
conflict’s role in driving Yemen’s cholera epidemic, how we measure conflict, infrastructure’s role in disease
dynamics, and enhancing preparedness efforts.
This F31 training fellowship will enable me to expand upon my background in conflict and health research
and learn new skills in disease ecology, earth observation, and advanced statistical methods during my PhD
dissertation work at the University of California, Irvine. I will be mentored by a team of subject-matter and
methodology experts who will help me develop the skills necessary to complete this proposed research. This
fellowship will also allow me to gain invaluable experience to prepare for a career as an independent researcher,
including grant writing and team management, which would otherwise be difficult to obtain due to teaching
commitments. Together, this fellowship and supported training will aid in my career goals of robust research on
the conflict and health nexus that can fuel preparedness, support advocacy, and reduce morbidity and mortality.

Public health relevance
Project Narrative The ongoing protracted Yemeni conflict has led to widespread infrastructure destruction, adverse health outcomes, economic collapse, and displacement. This proposed research will measure conflict’s association with cholera incidence while accounting for other relevant factors, utilize earth observation to measure infrastructure damage to predict cholera cases, and project the likelihood of future cholera outbreaks given likely conflict, climate, and economic scenarios. Together, these objectives will enhance preparedness efforts by improving the understanding of cholera’s drivers in this region and applying that knowledge to the future.